“CRCNS: Computational principles of memory based decision making in Drosophila”

Decision making largely depends on the integration of prior sensory experiences that are stored in the
brain as memories. One of the best-understood model systems of a two-choice decision process is
associative olfactory memory in Drosophila. In the fly, learning occurs at the synapse between Kenyon cells
(KCs) and mushroom body output neurons (MBONs). By pairing olfactory stimuli with a reward or a
punishment flies can reliably learn to distinguish two initially neutral odors. As in mammals, dopaminergic
neurons (DANs) represents this contextual valence and modulate the strength or connectivity of KC>MBON
synapses within distinct compartments of the MB, consequently altering behavior. To understand how this
decision making is encoded in memory we thus must first understand the computation performed within
individual DAN-KC-MBON modules. In preliminary work, we built a realistic computational model of the
MBON-3 neuron including the precise synaptic connectivity all 948 innervating KCs based on the complete
synaptic connectome of the MB. Our model incorporates precise membrane properties of the MBON-3
neuron that we obtained by performing patch-clamp recording in vivo. We demonstrate that MBON-3 is
electrotonically compact and show that activation of complex KC input patterns reflecting physiological
activation by individual odors in vivo are sufficient to robustly drive MBON spiking. Here, we will combine
experimental analysis in vivo with computational modelling to determine the mechanisms controlling MBON
activation under baseline conditions and in response to memory-induced plasticity. We will identify the
minimal number of KCs and KC synapses required for robustMBON activation for different subsets of
approach and avoidance MBONs in vivo. These data will guide computational approaches to identify
general and specific features of the KC-MBON interactions. The results will then serve to identify
compartment-specific plasticity mechanisms in vivo, and corresponding computational mechanisms in
silico. Finally, we extend these approaches to simultaneous analyses at multiple KC-MBON modules to
provide a computational basis for decision-making.

Public health relevance
Understanding the neural circuitry of smell signaling not only helps us to repair this process if it is damaged but it also helps to understand how smells influence behavior. This is of particular interest in decision making, one of the most central function of cognition whose deficiencies strongly affect human health, resulting in a large number of mental and psychiatric diseases. This research contributes to understanding how memory traces are laid down and retrieved, and how odor-related memory processes lead to behavior changes and decision making.